Non-B DNA structure discovery and function assessment using nanopore translocation times

Abstract
The canonical double helical structure of DNA (B-DNA) allows for stability and high-fidelity replication, but
emerging evidence suggests an increasingly important role for non-canonical (or non-B) DNA structures in
the cell. Non-B DNA structures have been (a) implicated in genetic disorders and carcinogenesis due to their
increased mutability, (b) associated with variability in promotor activity, and (c) established as a substrate
and site of localization for human telomerase and a putative mechanism for specifying centromere identity.
Experimental discovery of non-B DNA structures requires specialized, low-throughput protocols that can be
prohibitively expensive and typically target a subset of non-B DNA types. Computational methods offer a
lower-cost and higher throughput alternative, but rely on DNA base motifs resulting in two fundamental
limitations: (1) few regions having non-B DNA motifs are occupied by non-B DNA structures at any point in
time, and thus non-B DNA structure predictions have high false-positive rates that typically limit analyses to
aggregate statistics; and (2) non-B DNA structures without well-characterized DNA base motifs are missed
entirely. The inability to reliably and efficiently predict non-B DNA structures is a major scientific gap that
delays the characterization non-B DNA’s role in medically relevant biological processes and disease.
Recently, we discovered that non-B DNA motifs are associated with significant variability in the DNA
translocation speeds of nanopore sequencing. We developed predictive models to infer where non- B
structure is likely to form among locations occupied by non-B DNA motifs using translocation times as
features and performed extensive in silico validation of the predicted structures. While these preliminary
analyses demonstrated the feasibility of non-B DNA structure prediction from nanopore sequencing, several
significant technical limitations and scientific knowledge gaps limit the tool’s generalizability and
performance; we propose to resolve these issues by pursuing two aims: (1) predict and validate non-B DNA
structures using nanopore translocation times and other molecular sequencing dynamics; and (2) assess the
functional relevance of non-B DNA structures for clinically relevant phenotypes. Successful completion of this
project will provide software tools that enable efficient and precise characterization of non-B DNA structures
at the single sample level from third-generation sequencing platforms. The proposed research will also
generate novel associations between non-B DNA structures and clinically relevant phenotypes. Well-
documented and open-source tools will be made easily accessible for usage in new study designs or to
reanalyze existing third-generation sequencing data.

Public health relevance
Narrative The proposed research develops the first computational tools to predict non-canonical (i.e., not a right- handed double helix) DNA structures using molecular sequencing dynamics. The project validates these non-canonical structures based on computational benchmarking and function assessment with respect to clinically relevant phenotypes. Successful completion of this project will (a) provide open-source tools that enable fast and precise characterization of non-canonical DNA structures (in either existing or prospective studies) and (b) generate novel associations between non-B DNA structures and clinically relevant phenotypes.